Epigenetic Biomarkers of Postpartum Psychosis

Abstract
Reproductive mood episodes, such as postpartum depression, premenstrual dysphoric disorder and
postpartum psychosis, are mood episodes triggered by reproductive hormonal changes in women. We have
previously identified two epigenetic biomarkers of postpartum depression at the TTC9B and HP1BP3 genes
that are approximately 80% accurate in predicting which women will be depressed in the postpartum time-
period. We have recently shown that these biomarkers are also associated with women that have premenstrual
dysphoric disorder when blood is sampled in the luteal phase of the menstrual cycle indicating that they may
be more general biomarkers of brain sensitivity to reproductive hormone fluctuations. This proposal will take
advantage of a unique sample of blood specimens collected in the Netherlands from women with Postpartum
Psychosis and will determine if our epigenetic biomarkers are also associated with Postpartum Psychosis. We
will also conduct a genome wide microarray analyses in order to identify epigenetic biomarkers that are
specific to Postpartum Psychosis. Postpartum psychosis is a serious psychiatric illness with acute onset in the
immediate postpartum time period. Postpartum Psychosis almost always requires psychiatric hospitalization
and carries with it an elevated risk of suicide and infanticide. Identification of blood-based biomarkers that are
predictive of an increased risk for Postpartum Psychosis would allow for preventative measures which may
eliminate a psychiatric emergency and prevent hospitalization during the critical postpartum time period.

Public health relevance
Project Narrative Reproductive mood disorders are mood episodes that are triggered by times of reproductive hormonal fluctuation in women and include disorders such as postpartum depression, premenstrual dysphoric disorder and postpartum psychosis. We have previously identified two epigenetic biomarkers of postpartum depression that have recently proven to be associated with premenstrual dysphoric disorder as well. This project will determine if these same biomarkers are associated with postpartum psychosis, a potentially deadly reproductive mood disorder and, in addition, perform a genomewide methylation study to identify epigenetic biomarkers unique to postpartum psychosis. If successful, the biomarkers could allow prevention of this devasting psychiatric illness.